Systematic Evidence Reviews (SERs) to Support the Update of Expert Panel Report Guidelines.

AHRQ will perform Systematic Reviews and related scientific projects for NHLBI through the contract with the Evidence-based Practice Centers (EPCs) AHRQ-15-10001. NHLBI needs AHRQ’s services to complete analyses to develop systematic evidence reviews on asthma key questions that NHLBI and partner organizations will use in updating asthma clinical practice guidelines.